Administrative Core

Administrative Core
Project Summary
The Administrative Core Module provides support for the overall administration of Yale's Core Grant for
Vision Research. The Program Director is Jonathan Demb, Ph.D., who will be assisted by an Executive
Committee composed of the Directors of the three resource/service Core modules and an administrative
assistant, who will help manage grant-related issues, including ordering, maintaining equipment, generating
reports and maintaining records of Core module usage. An Advisory Committee, composed of senior faculty
and administrators, will evaluate and provide feedback on the Core program annually. The administrative
structure of this Vision Core Grant will ensure the smooth function of Core facilities and appropriate access
for all vision researchers at Yale, with priority given to NEI-funded investigators and new faculty applying for
their first NEI grant. The ultimate goal of the Administrative Core is to provide infrastructure to organize and
coordinate the efficient running of the entire Yale Vision Research Core Program and facilitate the research
projects of all Vision Core investigators at Yale.